Cell-specific plasticity pathway dysfunction as a result of amyloid deposition in Alzheimer's Disease

Alzheimer’s disease (AD) is the sixth leading cause of death in the general population and develops at a 60%
higher rate in the Veteran Population. Traumatic brain injury (TBI) and post-traumatic stress disorder (PTSD)
are associated with the development of amyloid and tau pathology and increase the rate of cognitive decline,
ultimately resulting in significant morbidity to veterans and their families. Altered plasticity and neurotransmitter
pathways are strongly implicated in cognitive dysfunction associated with Alzheimer’s disease since they
compromise the integrity of neuronal circuits. Understanding the mechanisms of plasticity dysfunction will allow
us to identify specific checkpoints that can be targeted in the future to restore function, potentially ameliorating
Alzheimer’s cognitive sequelae.
Outstanding questions include: 1) what cell-specific transcriptomic abnormalities reflect plasticity pathway
pathophysiology in Alzheimer’s disease, 2) what is the topographic relation between the location of b-amyloid
deposits and the manifestation of transcriptomic and functional (neuronal response properties) abnormalities in
different cell types, 3) how does the transcriptomic and functional profile of circuit dysfunction deteriorates during
disease progression? To probe the capacity of cortical circuits for plasticity we use a well-validated implicit visual
learning paradigm (stimulus-selective response potentiation or SRP) introduced by M Bear. Implicit learning
developed phylogenetically earlier than conscious learning, is ubiquitous in the neocortex and plays a
fundamental role in re-shaping cortical circuits to meet changing environmental demands. It is a true memory
phenomenon that shares core molecular features with LTP, requires sleep for consolidation and has a behavioral
correlate. Working in the visual cortex confers a strong advantage for dissecting circuit mechanisms of plasticity
dysfunction in AD, since excellent control of the input allows a precise quantification of how neuronal properties
change with learning in a particularly well-studied neocortical circuit.
We will use chronic in vivo 2-photon imaging to measure neuronal responses before and after SRP as a function of
distance from b-amyloid deposits at different stages of disease progression, in the 5xFAD mouse model of AD.
Two-photon measurements will be complemented with the recently developed high-throughput multiplexed error-
robust fluorescence in situ hybridization (MERFISH) imaging, to dissect how mRNA expression profiles change in
different types of neurons and glia as a function of distance from b-amyloid foci. Aligning in vivo imaging with cell-
specific MERFISH images obtained in vitro from the same tissue, will link abnormal neuronal responses and
plasticity profiles to transcriptomic signatures obtained from the same neurons. An added benefit of this is that it
can potentially extend our observations to the earliest period of malfunction, preceding amyloid plaque formation.
Aim 1. Use chronic in vivo 2-photon calcium imaging to study how pyramidal neuron responses change with
SRP-training as a function of distance from b-amyloid plaques in the 5xFAD mouse model of amyloid deposition,
at different time points in AD progression. Goal 1: Identify neuronal response biomarkers of abnormal plasticity
as a function of distance from b-amyloid plaques, including early in the disease progression potentially preceding
b-amyloid deposition. Aim 2. Use MERFISH to map single-cell-specific transcriptomic profiles of plasticity and
neurotransmitter-receptor pathways before and after SRP training, in the 5xFAD mouse model. Goal 2: Define
how cell-specific transcriptomic dysregulation of plasticity and neurotransmitter-receptor pathways manifests with
proximity to b-amyloid deposits as well as in relation to abnormal neuronal responses and plasticity profiles.
In summary, the pipeline developed will characterize AD associated plasticity-pathway transcriptomic dysfunction
in a topographically resolved cell-specific way, linking it to in vivo profiling of neuronal function. In time, we expect
this approach to prove valuable for answering a broad range of pathophysiological questions about additional
pathways implicated in Alzheimer’s disease as well as in a host of other neurological disorders.

Public health relevance
Alzheimer’s disease is the sixth leading cause of death in the general population and develops at a 60% higher rate in the Veteran Population. Traumatic brain injury and post-traumatic stress disorder, common in the Veteran Population, are associated with the development of amyloid pathology and cognitive decline, causing significant morbidity to Veterans and their families. Altered plasticity and neurotransmitter pathways are strongly implicated in cognitive dysfunction associated with Alzheimer’s disease. Here, we propose to use state of the art in vivo calcium imaging and single-cell-specific spatial transcriptomic microscopy to dissect how neuronal plasticity mechanisms degrade as a function of distance from b-amyloid foci in the 5xFAD mouse model of amyloid deposition. Understanding the mechanisms of plasticity dysfunction at the circuit level promises to yield new therapeutic targets for ameliorating Alzheimer’s cognitive sequelae in the future. This underscores the high potential impact of this project for the Veteran Population.